DOUBLE BLIND COMPARISON OF ZDV VS D4T FOR PATIENTS WITH HIV INFECTION

This study seeks to determine the safety and tolerance of Stavudine (D4T) as compared with zidovudine (ZDV or AZT) in patients with HIV.